Identification of smooth muscle cell genes causal in atherosclerotic plaque stability and cardiovascular disease risk

Despite effective LDL-C therapies, cardiovascular disease (CVD) risk remains a major unmet clinical need. We
and others have identified >300 loci for coronary artery disease (CAD). Genes that function in vascular smooth
muscle cells (SMC) are causal at several loci yet the causal genes at most loci remain unknown. Using single
cell profiling and SMC lineage-tracing in mouse models, we found that SMC transition through an intermediate
SMC-derived cell (SDC) state into protective or harmful phenotypes that modulate disease. We hypothesize that
SMC genes play a prominent causal role in plaque instability and CVD risk independent of lipoprotein genes. To
address this, we will leverage unique mouse model and human resources, including the Pakistan Genomics
Resource (PGR, n=250,000 for study) that includes the largest global cohort of human gene knockout “KOs”
(complete KOs >5000; heterozygous KOs >18,000 genes) as well as the Munich Vascular Biobank (MVB) with
>2,000 human plaques and clinical, histology, transcriptomics and genetic data. In Aim 1, we will integrate SMC
lineage tracing in mouse models with analyses of >1 million participants with GWAS SNP, whole-exome (WES)
and whole-genome (WGS) data, eliminating all loci/genes associated with plasma lipoproteins. Implementing
the largest rare variant and gene burden testing for CAD to date, we will prioritize likely causal SMC/SDC genes
and reveal predicted loss of function (pLoF) variant directional effects. To operationalize call-back studies, we
will limit to genes with at least 5 pLoF carriers in PGR. Gene priority will be refined by multiethnic fine-mapping,
co-localization analyses and biological plausibility. We expect to prioritize ~30 SMC/SDC genes. All will undergo
large PheWAS for pleiotropy and safety. For the top 5 genes, call-back studies will validate causality and
directionality and assess safety through deep phenotyping of atherosclerosis traits, safety and pleiotropy markers
in PGR families (n=200 per family). Preliminary work prioritized 15 SMC/SDC genes, all strong causal
candidates, and initial call-back in PGR expanded large pedigrees for the most promising genes (e.g., PDE3A,
SERPINH1, HHIPL1, ZEB2). In Aim 2, we will use RNA in situ sequencing (HybRISS), RNA-scope, proximity
ligation assays (Myh11-H3K4me2 SMC/SDC mark) and histology to define SMC/SDC gene expression and
location for ~30 prioritized genes in stable vs. unstable MVB plaques. Change in allele specific expression for
genes in SDC types in stable vs. unstable MVB plaques and co-localization of their cis-eQTLs to CAD SNPs will
inform causal and directional effects on plaque stability. For at least 2 top genes, we will use a Tet-on Dre/Cre
dual inducible recombinase system for SMC gene deletion at late time points to test effects and mechanisms on
features of plaque stability in advanced lesions and disease regression. We are poised to test in mouse models
if PDE3A, one compelling example, promotes SMC proliferation, senescence and vascular remodeling. Overall,
we propose a unique integrative platform, validated by human genetics, to fine-map loci, discover causal genes
and elucidate safe therapeutic targets in SMC/SDCs causal pathways for atherosclerosis stability and CVD risk.

Public health relevance
Despite effective cholesterol-lowering therapies, cardiovascular disease (CVD) risk remains a major unmet clinical need. We hypothesize that genes expressed in the artery smooth muscle cells play a prominent causal role in atherosclerotic plaque instability and CVD risk independent of genes affecting blood cholesterol level. To address this, we propose a unique integrative approach, validated by natural “human knockouts,” to fine-map the genome regions for CVD, discover causal genes, and elucidate safe therapeutic targets for smooth muscle cell casual pathways in atherosclerosis stability and CVD risk independent of blood cholesterol.